Interrogating the Role of Bacterial Methyl-modifying Enzymes in Pathoadaptation and Host Epigenetic Interference in Cancer

PROJECT SUMMARY/ABSTRACT
The proposed study seeks to determine if DNA methyltransferases from members of the microbiota contribute
to bacterial pathoadaptation in the tumor niche, direct xenogeneic epi-modifications on the human genome, and
can be exploited as therapeutic targets in cancer prevention/treatment. Within a patient’s tumor, malignant cells
are surrounded by a complex microenvironment encompassing a range of non-transformed cells and also a
diverse collection of microorganisms. For example, Fusobacterium nucleatum (Fn) is significantly enriched in
colorectal adenocarcinoma compared to adjacent normal tissue. Although cellular and animal models have
supported a role for this bacterium in cancer initiation and progression, we still have little information as to how
they directly contribute to cancer. In published work, our group has demonstrated that Fn, which is usually part
of the oral microbiome and not found in the lower gastrointestinal tract, is an invasive intracellular bacterium that
effectively colonizes the colorectal cancer (CRC) niche. In preliminary studies, we isolated and characterized the
genomes and epigenomes of >150 Fn strains from CRC tumors and the oral cavity and discovered that within
the Fn subspecies Fn subsp. animalis, there are two distinct clades that differ in their enrichment in CRC, which
we named Fn oral-clade and Fn CRC-clade. We show that Fna CRC-clade is the only Fn group significantly
enriched in human tumors and fecal specimens. Of the many differences between these two clades, perhaps
one of the most striking is their distinct DNA methylome signatures, with CRC-clade uniquely harboring Gm6ANTC
methyl-modifications. We, therefore, hypothesize that the DNA methyl-modifying enzyme (M.FnI) responsible for
m6A methylation at this motif contributes to Fn CRC-clade virulence during carcinogenesis. We propose to test
this hypothesis using genetically engineered CRC-clade clinical isolates in cell culture and animal model
experiments to determine if M.FnI regulates bacterial gene expression to promote their pathoadaptation (Aim 1).
Additionally, we speculate that M.FnI can act as a nucleomodulin to directly interfere with the human host
epigenome and gene regulation. We will investigate this possibility through ectopic expression of M.FnI in human
CRC cell lines and pre-cancer organoid models to delineate its nucleomodulin potential (Aim 2). Finally, we seek
to develop chemical probes specific for M.FnI to aid in authenticating it as a therapeutic target in CRC prevention
and progression (Aim 3). While we focus here on a single pathogen and single disease, successful completion
of these aims will provide fundamental knowledge on the role of microbial epigenetic systems in tumor colonizing
microbes. Further, this work has potential to reveal a hidden paradigm of host microbe-epigenetic crosstalk
underlying the oncogenic process in bacterial-colonized, hypermethylated tumors. As such, if our core
hypothesis is true, this work could have a far-reaching impact beyond CRC.

Public health relevance
PROJECT NARRATIVE Members of the human microbiota have been shown to play an important role in cancer initiation and progression, but the underlying mechanisms remain largely unknown. Building on novel insights from published and preliminary studies in bacterial epigenetics, mammalian epigenetics, and cancer microbiome research, we propose that bacterial enzymes called DNA methyltransferases, which are abundant within the human microbiota, can drive colon cancer development by promoting bacterial virulence as well as modify the human cell genome. If successful, we will uncover a novel host-microbe interaction that could be targeted for disruption as a strategy to prevent or treat cancer